Parenting STAIR: Adapting a Trauma-Focused Parenting Intervention for Military-Connected Mothers and Their Children

PROJECT SUMMARY/ABSTRACT.
Military-connected mothers (MCM; mothers who are either service members or veterans, or spouses of a service
member or veteran) experience significant trauma exposure associated with post-traumatic stress symptoms
and ultimately deficits in parental functioning. Maternal trauma and its mental health and functional sequelae can
have significant consequences for children, including adverse mental health outcomes. Existing evidence-based
treatments (EBT) available to MCM to address trauma have not been adapted for military culture and do not fully
resolve symptoms or address the bi-directional relationship between symptoms and parental functioning. To
address this gap, in this R21, we propose to adapt and collect preliminary data on an innovative intervention,
Parenting-STAIR (PSTAIR), which addresses trauma symptoms and parenting among MCM. PSTAIR is a novel
intervention, combining two existing EBTs: Skills Training in Affective and Interpersonal Regulation Narrative
Therapy (STAIR), targeting maternal emotion dysregulation and mental health symptoms, and dyadic Parent-
Child Care (PC-CARE), targeting parental functioning. In an open pilot with child-welfare involved mothers, 23
session PSTAIR dramatically reduced symptoms, improved parenting skills, and prevented maltreatment.
However, non-trivial treatment dropout and nonresponse consistent with other trauma- and parenting-focused
EBTs were also observed; results suggest shortening and individualizing treatment may offer solutions to
address dropout and nonresponse. Guided by a heuristic framework for cultural adaptation of behavioral
interventions, the present study will proceed in three phases. In phase 1, we conduct qualitative interviews and
focus groups with key informants including MCM to guide adaptation of PSTAIR in Phase 2. Adaptation will be
guided by qualitative findings and informed by novel approaches to shorten and individualize EBTs to address
dropout and nonresponse, including modular and adaptive design elements and shared decision-making
between participants and clinicians. We anticipate the outcome of Phase 2 will be a 10-15 session intervention
(PSTAIR-M), involving a compact version of PSTAIR in Module 1 and tailored options for Module 2, focusing on
mental health (Module 2a) and parental functioning (Module 2b), implemented based on response to Module 1.
Phase 3 will involve a pilot randomized controlled trial conducted in a community mental health setting, in which
we will randomly assign N=120 trauma-exposed MCM who screen positive for PSTD with/without comorbid
depression and one identified child (ages 2-10) to PSTAIR-M or treatment as usual. In Phase 3, we will also
collect critical data on mechanisms which may account for observed effects of PSTAIR. Pilot data collection will
set the stage for a future R01 in which we will conduct a full-fledged mediator-moderator clinical trial. Successful
treatment with an efficient, personalized intervention has the potential to prevent adverse outcomes for MCM
and their children and to interrupt the intergenerational cycle of trauma in military family systems.

Public health relevance
PROJECT NARRATIVE: Though military-connected mothers experience high rates of trauma exposure and resulting mental health and parenting deficits, no culturally appropriate evidence-based interventions exist to address the associations between trauma exposure, mental health, and parenting in this population. This study adapts and preliminarily tests an innovative intervention, Parenting-STAIR (PSTAIR), which combines two existing evidence-based interventions (Skills Training in Affective and Interpersonal Regulation [STAIR] and Parenting-Child Care [PC- CARE]) to reduce mental health symptoms and improve parental functioning among trauma-exposed military- connected mothers. The adapted intervention will be brief and more targeted to the needs of individual mothers and will be further tested in a larger randomized clinical trial in a future study.